Northwest Reproductive Sciences Symposium 2024

PROJECT SUMMARY
In September 2024, the 19th Northwest Reproductive Science Symposium (NWRSS) meeting will be
hosted by Oregon State University at the OSU-Cascades campus in Bend, OR. This long-standing series
began in 1989 as the Washington State University (WSU) and the University of Idaho (UI) annual joint
minisymposium, but now rotates biennially between WSU/UI, Oregon State University (OSU), and Oregon
Health & Science University (OHSU). The scientific program serves to showcase the high quality of regional
research in reproductive sciences, fertility and contraception, developmental biology, and animal and human
health. The objective of the NWRSS meeting is to promote the exchange of information to advance our
collective understanding of the mammalian reproductive tract both in normal function and in pathophysiological
dysfunction. Because most of the attendees are concentrated in the Pacific Northwest region, many lasting
collaborations arise from these gatherings. The NWRSS meeting also seeks to support career development
within all aspects of reproductive biology, enabling interaction between trainees, new investigators, and
established principal investigators. The training mission of the NWRSS extends to meeting organization as
well, as an ad hoc trainee committee from all participating schools is solely responsible for organizing the
scientific sessions into thematic groups, selection of trainee platform speakers, as well as serving as session
chairs during the meeting. The majority of NWRSS talks are delivered by post-doctoral fellows as well as
graduate and even undergraduate students. Similar to 2022, in addition to Keynote address from a preeminent
leader in the field of reproductive biology, invited speakers addressing health disparities in reproduction and
diversity in STEM fields will be featured. NWRSS organizers and participants are committed to providing a safe
and inclusive environment to foster the sharing of ideas between developmental biologists, molecular
biologists, systems biologists, population health biologists, and clinicians working in reproductive biology.

Public health relevance
PROJECT NARRATIVE The goal of the Northwest Reproductive Sciences Symposium (NWRSS) series is to promote the productive exchange of ideas and foster an environment in which trainees, early-stage investigators, and senior scientists can share their work and develop lasting collaborations. To this end, since its inception in 1999, 71% of NWRSS participants have been trainees or junior scientists, >60% women, and ~25% underrepresented minorities. The NWRSS is committed to fostering a diverse and inclusive environment which makes a significant impact on the training of young investigators to advance reproductive science and bring fresh ideas to translational research involving reproductive biology.